Identifying the mechanisms of latent inhibition to prevent dental fear

PROJECT SUMMARY
Our recent findings as well as others, show pre-exposure to dental stimuli prior to a conditioning event results
in latent inhibition (LI). The reverse is also true, lack of pre-exposure is related to greater fear, poorer oral
health, increased likelihood of cancellation of dental appointments, decreased likelihood of compliance with
the recommended schedule of dental visits, and failure to maintain an ongoing relationship with a dental office.
Although findings across studies converge on LI as clinically relevant for the prevention of dental fear, this fact
has not been leveraged to develop prevention programs nor have the necessary experimental investigations
been undertaken to identify the target mechanisms responsible for LI of dental fear. There are currently no
evidence-based prevention strategies for dental fear and existing prevention strategies for related anxiety
disorders are typically low-dose versions of diffuse treatment programs without a specified mechanism of
action. The purpose of the proposed study is to identify the mechanism(s) underlying the LI of dental fear,
allowing for more precise engagement of these target(s), and to examine whether individual differences related
to ethnicity that could help account for the disparities observed in oral health and dental fear, are related to the
engagement of these targets. We hypothesize that changes in prediction errors and attention that result from
pre-exposure account for latent inhibition of conditioned fear and that higher pain sensitivity increases the
engagement of these mechanisms. We propose studies that manipulate pre-exposure in a novel virtual reality
paradigm, developed and validated by members of our team, to affect the target mechanisms. In addition to
assessing attention and prediction errors, we will examine the endpoint of fear, using measures of behavior,
subjective emotion, and physiological change. The proposed research is innovative in that it is the first to apply
a well-characterized model of learning to the LI of dental fear using an experimental medicine approach; it uses
a newer paradigm that allows for the assessment of behavior in the context of clinically-relevant conditions of
mixed approach/avoidance motivation, with environmental contingencies that allow for detection of individual
differences, including those with the potential to address oral health disparities. Moreover, the approach used
includes participants of both sexes across the lifespan, and short and longterm retention tests, noted omissions
in the extant literature on human fear conditioning. These studies are relevant to public health because over 40
million Americans suffer from significant dental fear with the potential to negatively impact oral health and
downstream health sequalae. The proposed studies are relevant to clinical practice because the lack of precisely
defined and measurable targets for prevention of dental fear is a critical barrier to the development of
evidence-based, cost-effective prevention strategies with the scalability to effect change in the population.
Moreover, the proposed research responds the priorities identified by NIDCR in the 2030 visioning initiative to
integrate oral health and overall health, enable precise, personalized care, and, address oral health disparities.

Public health relevance
PROJECT NARRATIVE Over 40 million people in the US are afraid of getting needed dental care, and we currently lack the strategies for preventing the learning processes that cause dental fear. The proposed project aims to determine which processes to target to prevent dental fear when one has a bad experience at the dentist.